Hyperpolarized C-13 MRI for Early Detection of Aggressive Prostate Cancer in Active Surveillance Patients

PROJECT SUMMARY/ABSTRACT
This revised project is designed to investigate a new safe, non-radioactive HP 13C mpMRI exam approach for
creating a metabolic imaging solution for the unmet clinical need of detecting aggressive prostate cancer in
patients prior to enrollment or on “Active Surveillance” with correlations to “gold standard” MR/US fusion-
guided biopsy findings, and other clinical measures including current imaging parameters. This project was
designed to fit the goals of PAR-16-089 Imaging and Biomarkers for Early detection of Aggressive Cancer that
states: “The specific objective of this FOA is to stimulate and support cancer imaging and biomarker research
to develop, optimize, and clinically validate novel methods” to address the ““unmet clinical need to more
accurately identify early-stage aggressive cancers and distinguish lesions that are life threatening from those
that are not”. In response to the prior critique, we have significantly modified this study application following the
reviewers' suggestions and addressing their concerns.
The clinicians on our multidisciplinary team designed this revised study based on their unmet need to identify
which untreated prostate cancer patients (thousands per year) have only low risk disease and can be managed
by Active Surveillance (AS) and which have aggressive cancer, missed on biopsy, but still organ-confined and
should be treated. Molecular imaging with FDG- or PSMA-PET is used for detecting metastatic disease, but
high uptake in the bladder and normal prostatic tissues hinders the critical detection of high-grade cancer
within the prostate. Based on strong preliminary preclinical & patient data showing a significant correlation of
elevated HP 13C-pyruvate to 13C-lactate conversion in high grade prostate cancer, our clinical team created this
study design testing improved, safe, lower-cost HP 13C MR molecular imaging techniques as a 5min addition to
a standard-of-care mpMRI exam with correlations to subsequent MR/US fusion-guided biopsy findings; “gold-
standard” for this patient population. We aim to study patients (N=110) referred for mpMRI either to rule out
missed aggressive disease at biopsy diagnosis prior to deciding on AS or as a consequence of a rising PSA
while on AS. Also a subset (N=44) of these patients that enter AS, will be followed yearly with HP+mpMRI
exams followed by MR/US fusion-guided biopsies in order to determine if a significant increase in kPL of any
intra-prostatic lesion is an early predictor of disease progression (Gleason score upgrading). The success of
this project could have exceptional clinical impact including: 1) Increased confidence that those entering AS do
not have aggressive prostate cancer; 2) Early detection of aggressive cancer in AS patients; and 3) Improved
guidance of biopsy and subsequent treatment of metabolically aggressive organ-confined cancer.

Public health relevance
PROJECT NARRATIVE The goal of this prostate imaging project is to investigate the addition of a new safe, non-radioactive 5-minute hyperpolarized 13C-pyruvate MR scan to a clinical mpMRI exam in order to create a metabolic imaging solution for the unmet clinical need for the detection of aggressive cancer in the prostate in patients prior to and enrolled in “Active Surveillance”. Success of this project would improve the detection of aggressive cancer missed by biopsy sampling error enabling earlier treatment decisions or increased confidence in selecting Active Surveillance for more patients; thus reducing overtreatment.